Administrative Core

PROJECT SUMMARY
This Core component is intended to provide administrative and fiscal oversight to the operations of the 3
individual Research Projects and the Scientific Core Component. There are 3 specific aims:
1. Promote integration of individual scientific projects in the context of the Program themes.
2. Coordinate review of scientific activities by internal and external advisory groups.
3. Provide administrative support in the form of fiscal oversight for Program-related expenditures in individual
projects, coordination of program related services provided by the Core, and responsibility for the preparation of
progress reports and continuation applications on an annual basis.
These goals will be accomplished through the activities of the administrative unit and the internal and external
advisory groups.

Public health relevance
PROJECT NARRATIVE The Administrative Core provides administrative support to the Program Project to enable efficient cooperation among constituent projects and to serve as the interface between the Program Project, the advisory boards and the NCI.